Increasing initiation of evidence-based weight loss treatment

PROJECT SUMMARY/ABSTRACT
Comprehensive behavioral treatments are effective at promoting weight loss and improving clinical outcomes
among adults with obesity. However, a large majority of individuals with obesity never take the first step of
initiating these treatments (even when barriers to cost and access are reduced), severely limiting the
population impact of evidence-based weight management treatments. To address this challenge and take
advantage of growing access to comprehensive weight loss treatments, our team has developed a tool
designed to increase initiation of evidence-based behavioral weight loss treatments among eligible but non-
treatment seeking adults (“mobilization tool”). As part of this tool, patients answer brief questions and receive
automated, individually tailored feedback. This feedback targets empirically and theoretically relevant
constructs for treatment initiation using a Motivational Interviewing approach that supports patient autonomy.
The tool is completed by patients in the days prior to a scheduled primary care appointment and contains
explicit endorsement by patients’ primary care provider (PCPs), taking advantage of PCPs’ influence while not
relying on PCPs to initiate weight counseling. It is also designed to be low burden and high acceptability to
PCPs to facilitate dissemination, if effective. We previously conducted a cluster randomized feasibility pilot trial
to inform plans for a fully powered test of the effectiveness of the mobilization tool. The pilot showed that the
tool was highly usable, informative, and enjoyable; feasibility goals were met; and a signal of an effect was
observed. We are now prepared to conduct an adequately powered cluster randomized clinical trial to compare
the effects of the mobilization tool and a static treatment description (comparator tool), and to examine how
effects differ across key demographic factors. We will recruit and randomize PCPs (n=36) and patients with
obesity (n=828) who have an upcoming appointment with enrolled PCPs. All enrolled patients will complete
either the mobilization tool or the comparator tool, depending on their randomization arm, and will be informed
that they have free access to comprehensive weight loss treatment. We will compare the two study arms on
the proportion who initiate weight loss treatment (primary outcome), session attendance, and weight loss
outcomes at 6 months (secondary outcomes). Because weight loss programs historically have had lower
uptake by individuals who are men, Black/African American, younger, have lower income, and have lower
educational attainment, we will recruit a diverse population to allow for comparisons of effects across gender,
race, age, income, and education. If effective, the proposed mobilization tool could be disseminated within
primary care practices to increase the number of adults with obesity who initiate evidence-based weight loss
treatment, resulting in greater population weight loss and meaningful changes in population health.

Public health relevance
PROJECT NARRATIVE The vast majority of adults with obesity do not enroll in comprehensive evidence-based behavioral weight loss programs and as a result are less likely to achieve clinically meaningful weight loss. This study will test the effects of a brief, individually tailored intervention aiming to increase initiation of comprehensive behavioral weight loss treatment on weight. If the intervention is effective, it could be disseminated within primary care practices to increase the number of adults with obesity who achieve clinically meaningful weight loss.